Evaluation of the prevalence of xylazine and etiology of xylazine related invasive infections

ABSTRACT / PROJECT SUMMARY
Xylazine is an alpha 2 adrenergic receptor agonist with sedative and analgesic properties which is increasingly
being found in the US illegal drug supply and linked to numerous adverse health outcomes including overdose
deaths, skin ulcerations and infections. Public health efforts are limited by a lack of data on the type of illicit
controlled substances that have been adulterated by xylazine, while at the same time clinicians face an
increasing number of patients presenting with large painful skin ulcerations, many of which are complicated by
necrotizing infections or underlying osteomyelitis. However, it is unclear to what degree these xylazine related
complications are the result of infections due to pathogens directly injected from a contaminated drug supply,
compared with secondary superinfections from skin colonizing microbes of vasoconstriction mediated chemical
injuries.
Our proposed grant application seeks to fill this critical gap in the literature. In aim 1 we will conduct active
surveillance of the local illicit drug supply in St. Louis Missouri using mass spectrometry and microbiologic
cultures of syringe residue. This will allow us to identify the full spectrum of illicit drugs associated with xylazine
while also performing ongoing surveillance for the potential emergence of any other novel adulterants.
Microbiologic analyses of syringe residue will allow us to determine if xylazine contaminated illicit drugs support
increased levels of bacterial contamination compared to other illicit drugs which might explain the high degree
of invasive infections associated with this novel adulterant.
Aim 2 will consent hospitalized patients with xylazine related invasive infections and compare bacterial
pathogens isolated from clinical specimens with skin colonizing microflora and bacterial and fungal species
isolated from xylazine containing syringe residue collected in Aim 1. By comparing core genome single
nucleotide polymorphism (cgSNP) distances we will determine if clinical sites of infection are the result of
bacterial superinfection from skin colonizing organisms or arose directly from bacterial species innoculated along
with xylazine containing illicit drugs.
The work proposed in this application has the potential to directly impact public health and patient care. A clear
understanding of what pathogens people who use xylazine are routinely exposed to, and an increased
understanding of the etiology of xylazine related infectious complications is urgently needed to guide public
health policy and target harm reduction interventions.

Public health relevance
PROJECT NARRATIVE Xylazine, an alpha 2 adrenergic receptor agonist with sedative and analgesic properties is rapidly infiltrating the United States illegal drug supply. Recent case series and reports from hospitals at the epicenter of this emerging epidemic have identified an overwhelming number of invasive infections, particularly cutaneous ulcers and necrotizing skin and soft tissue infections in people who use xylazine. This grant application will provide information on the types of illicit drugs contaminated with xylazine as well as microbiologic data on the types of pathogens contaminating xylazine adulterated drugs and causing severe infections in people who use xylazine.